B cell-adaptive Immune Profile in Emphysema-predominant COPD

PROJECT SUMMARY
Recent studies show that not all the COPD patients, but only those having emphysema present a prominent lung
B cell molecular signature irrespectively of the degree of airflow limitation. Our preliminary data show that lung
and circulating B cell responses are upregulated in COPD patients with greater vs. lesser emphysema within the
same COPD severity stage. We will test the central hypothesis that emphysema is characterized by changes in
B cell transcriptome which underlie exaggerated and off-targeted B cell responses contributing to lung
destruction. In Aim 1, we will test the hypothesis that B cell, lymphoid follicles (LFs), and B cell product counts,
and specific LF B cell clonal and post-transcriptional changes are increased in the emphysematous lung vs. lung
with lesser emphysema. In Aim 1A, we will immunostain, using both conventional immunostaining and image
mass cytometry, COPD and control lungs and correlate the numbers of B cells, LFs, and other cells involved in
B cells responses, with the extent of computed tomography (CT)-defined lobar emphysema. In Aim 1B, we will
use laser capture microdissection to extract LF B cells from COPD and control lung sections to then: 1) assess
the clonality of the LFs; and 2) study the rearrangement of the B cell receptor (BCR) using a next-generation
sequencing (NGS) assay. In Aim 2, we will test the hypothesis that an exaggerated B cell activation, associated
with transcriptomic changes, is present in the emphysematous lung. We will isolate lung B cells from COPD
patients and controls in order to: 1) test B cell activation and immunoglobulin (Ig) production in response to
antigens using in vitro cultures and ELISPOT assays; 2) characterize the B cell pool using flow cytometry (Aim
2A); 3) study lung B cell transcriptomes and BCR rearrangements using single-cell RNA sequencing
(scRNAseq); 4) generate monoclonal Igs and identify their binding targets in the lung with mass spectrometry
(Aim 2B). We will correlate the readouts of B cell activation in the lung with the extent of CT scan-defined lobar
emphysema. In Aim 3, we will test the hypothesis that circulating B cell function and phenotypes reflect lung B
cell features in correlation studies relating to the extent of emphysema. In Aim 3A, we will: 1) test blood B cell
activation and Ig production in response to antigens using in vitro cultures and ELISPOT assays; 2) characterize
the blood B cell pool using flow cytometry; and 3) study blood B cell transcriptomes and BCR rearrangements
using scRNAseq. In Aim 3B, we will use COPD and control plasma to: 1) quantify the blood Ig isotypes and
identify the blood Ig binding targets in the lung using mass spectrometry; and 2) measure the levels of B cell-
related biomarkers and IgG reactivity against lung matrix. We will correlate the readouts of B cell activation in
blood and lung from the same subject, with the extent of CT scan-defined emphysema. These studies will define
the nature of the B cell responses in a clinical phenotype (likely emphysema) which could benefit from therapies
targeting B cells or B cell products, leading to earlier and more personalized therapeutic intervention for COPD.

Public health relevance
PROJECT NARRATIVE In this proposal, we will test the central hypothesis that an upregulation of the B cell immune compartment in lung and blood correlates with the extent of emphysema in COPD independently of the severity of airflow limitation. We will use immunostaining and image mass cytometry techniques, next-generation sequencing with a single-cell approach, in vitro and ex vivo approaches to test our hypothesis that changes in the B cell transcriptomics are associated with an upregulation of the B cell pool in both blood and lung of COPD patients, contributing to lung tissue destruction and emphysema. The successful completion of these studies will help define the clinical phenotype (likely emphysema) that could benefit from therapies targeting B cells or B cell products, leading to earlier and more personalized therapeutic intervention which will greatly alleviate the burden of COPD.